Division of Cancer Prevention, Information Technology and Informatics SupportPeriod of Performance 09/22/2016 - 09/21/2017

To provide Information Technology and Informatics Support to the NCI Division of Cancer Prevention.